Transcriptional regulation in the ventricular conduction system

PROJECT SUMMARY
The ventricular conduction system (VCS) is critically important for normal myocardial excitation and
contraction. Heritable and acquired syndromes perturbing VCS formation or function are responsible for a
substantial burden of cardiovascular disease, including heart block, triggered and reentrant arrhythmias,
sudden cardiac death, as well as myocardial dyssynchrony and progression of heart failure. Using genetically
encoded conduction system reporter mice, comparative transcriptional profiling, and a battery of functional
assays, our laboratory has pioneered studies of VCS development, physiology and disease pathogenesis.
Through this approach, we have identified and characterized the transcriptional signature of Purkinje cells and
identified a number of novel genes that regulate diverse aspects of VCS biology, including transcription factors,
ion channel subunits and regulatory proteins. In the current application, we propose to establish a more global
and comprehensive understanding of gene regulatory networks that are operative in this rare population of
excitable cells, by extending our analysis to include microRNAs that are differentially expressed in the VCS.
More specifically, we propose to: determine the cell autonomous requirements for microRNAs in the VCS;
identify microRNAs required for Purkinje cell differentiation using functional genomics screens; and define
Purkinje cell transcriptional signatures and electrophysiology in health and disease.

Public health relevance
PROJECT NARRATIVE Heart disease is the leading cause of death in the United States and other developed countries and almost half of these deaths occur suddenly from heart rhythm abnormalities. Our research is directed toward understanding the mechanisms responsible for normal and abnormal heart rhythmicity with a particular focus on arrhythmic diseases that arise from abnormalities in the specialized cardiac conduction system. This project focuses on studies of transcriptional regulation of the specialized cardiac conduction system during development, normal physiology and in disease states.